Project 2 Biological Age in Myasthenia Gravis: Impact on Stratification and Treatment Response

PROJECT 2 ABSTRACT
Traditional approaches have predominantly used chronological age for disease stratification and treatment
planning. However, emerging evidence suggests that biological age—an integrative measure incorporating
genetic, environmental, and lifestyle factors—may offer a more accurate assessment of overall health and
treatment response. We hypothesize that patients with myasthenia gravis (MG) may have a biological age that
exceeds their chronological age and that effective treatment could lead to a reduction in biological age.
Specific Aim 1 will characterize biological age using proteomic, transcriptomic, and methylation profiles from
specimens obtained at the time of enrollment in the MGTX clinical trial of thymectomy (NCT00294658), which
includes patients aged 18 to 65 years. We hypothesize that MG patients will exhibit a biological age greater
than their chronological age. Specific Aim 2 will investigate the primary drivers of autoreactivity by assessing
the relationship between immunological aging—measured by mitochondrial activity and DNA methylation in T
lymphocytes—and the chronological onset of myasthenia gravis. We utilize the EXPLORE-MG biobank
developed by the MGNet in its initial funding period. Specific Aim 3 will evaluate whether MG treatment is
associated with a reduction in biological age and if a higher biological age predicts treatment resistance using
MGTX trial specimens. This study is pioneering in its application of biological age metrics in MG, moving
beyond chronological age to provide a more nuanced understanding of disease mechanisms and treatment
response. By establishing biological age as a biomarker in MG, this study aims to enhance subject stratification
for clinical trials, identify biological age as a treatment-responsive biomarker, and contribute to the broader field
of personalized medicine. The findings could pave the way for biological age to become a standard outcome
measure in future clinical trials of myasthenia gravis.